Racial Differences in Serum Sodium and Blood Pressure Regulation

PROJECT SUMMARY / ABSTRACT
CANDIDATE: Austin T. Robinson, Ph.D is a Postdoctoral Associate at the University of Delaware (UD). Dr.
Robinson aims to study racial differences in cardiovascular responses to high dietary sodium (Na+). He recently
published data demonstrating that compared to white individuals, 1) black individuals have augmented increases
in serum Na+ to a hypertonic saline infusion; and 2) exhibit higher blood pressure (BP) for a given serum Na+. In
this proposal, he will translate these findings by comprehensively assessing neurovascular responses to acute
(single meal) and chronic (10 days of a controlled feeding) high dietary Na+. The central hypothesis is that high
dietary Na+ influences sympathetic nerve activity similarly in black and white individuals; however, diminished
vasodilator capacity and augmented sympathetic transduction (vasoconstrictor responses to sympathetic nerve
bursts) contribute to exaggerated BP dysregulation in black individuals. He will also determine the role of lifestyle
factors (i.e., sleep, physical activity, and nutrition) on potential baseline racial differences in CV physiology.
CAREER DEVELOPMENT PLAN: Dr. Robinson proposes to enhance his career development by: 1) Acquiring
new skills in the assessment of sleep, assessment of (nitric oxide) NO. bioavailability, and assessment of reactive
oxygen species (ROS). 2) Advanced training in epidemiology to analyze large data sets. Specifically, he will
perform secondary data of samples collected for the Multi-Ethnic Study of Atherosclerosis (MESA) under the
guidance of advisor Dr. Norrina Allen, an expert epidemiologist. 3) Refining his professional skills though formal
course work, attendance and presentations at weekly journal clubs, and at national/international scientific
meetings. ENVIRONMENT: Dr. Robinson will train in an outstanding research environment supported by a multi-
disciplinary team of mentors. The primary mentor, Dr. Farquhar, is an NHLBI-funded full professor at UD with a
record of successful mentorship. He is an expert in autonomic control of circulation, and executing controlled
salt feeding studies. Co-mentor Dr. Edwards is also at UD and a leading expert in vascular physiology function
and executing controlled dietary salt feeding studies. Co-mentor Dr. Brown is an expert in lifestyle as a preventive
and treatment strategy for hypertension and vascular function in black individuals. Advisors Dr. Zimmerman and
Dr. Poole are experts in ROS and NO. signaling, respectively. Advisor Dr. Buxton is a recognized expert in sleep
and health consequences of sleep deficiency, especially cardiometabolic outcomes. Advisor Dr. Wright is a
professor in Nursing at UD and has expertise in neuropsychology and racial disparities. RESEARCH: Black
individuals are more prone to salt-sensitive elevations in BP and adverse cardiovascular conditions associated
with chronic high dietary Na+ intake compared to other racial groups. Racial disparities in vascular function and,
autonomic control of BP in black individuals under basal conditions also exist. There is a critical need to elucidate
the physiology underlying these racial disparities and to determine if these racial disparities are attributable to
lifestyle differences.

Public health relevance
PROJECT NARRATIVE Nearly nine in ten Americans overconsume salt, and black individuals are more prone to salt-sensitive hypertension and experience the adverse cardiovascular comorbidities associated with high dietary salt. We seek to test the hypothesis that acute (single meal) and chronic (10-day controlled feeding) high dietary salt leads to a greater impairment in conduit artery function and augmented sympathetic transduction, leading to exaggerated blood pressure dysregulation in black, compared to white, individuals. Importantly, we also seek to determine if lifestyle factors (sleep, habitual physical activity, diet, and mental health) modulate racial disparities in cardiovascular function at baseline and in response to acute and chronic high dietary salt interventions.